Fungal Melanin Modulation of Calcium-Mediated Responses in Lung Epithelium

PROJECT SUMMARY
Invasive pulmonary fungal infections carry unacceptably high mortality rates and contribute to over $2.4 billion in direct
healthcare costs in the US alone. The most prominent fungal pathogens causing lung disease include Aspergillus fumigatus
(Af). Although it is well demonstrated that the immune system is critical to a proper response to invading fungi, the airway
epithelium remains a vastly understudied component of antifungal immunity. We previously demonstrated that the
recognition of Aspergillus lacking the outer layer of 1,8-dihydroxy naphthalene (DHN) melanin by airway epithelial cells
leads to higher transmigration of neutrophils. Our preliminary data demonstrate that purified Af melanin (termed melanin
ghosts; MG) blocked the secretion of IL-8 and GROα by the epithelium, muted calcium fluxing, reduced phosphorylation
of key signaling molecules, induced distinct changes in the transcriptional signatures differentially in airway epithelial cell
subtypes, altered actin filamentation, and dampened the production of reactive oxygen species (ROS). These data argue that
fungal melanin actively triggers distinct immunomodulatory responses in primary human epithelial cells.
Thus, our overall testable hypothesis is that Af melanin blocks calcium fluxing, which silences inflammatory circuits (i.e.,
exocytosis pathways, TLR and CLR signaling pathways, and ROS production) in airway epithelial cells to subvert the innate
immune response.
To address this hypothesis, we propose the following three specific aims: [1] dissect the mechanism of how Af fungal
melanin inhibits chemokine secretion, [2] determine the TLR and CLR signaling pathways affected by Af melanin; and [3]
reveal the mechanism by which melanin blocks ROS production in lung epithelial cells. This work will identify the
mechanisms by which fungal melanin halts chemokine secretion by airway epithelial cells and define the pathway(s) altered
by this suppression through the lens of calcium signaling. Completion of this proposal will provide novel therapeutic targets
for invasive fungal infections caused by melanized fungi. Furthermore, lung diseases with the hallmark of a hyper-
inflammatory state, such as asthma, could be treated with synthesized melanin to dampen exacerbated inflammation.

Public health relevance
PROJECT NARRATIVE Invasive fungal infections are one of the most dreaded infections for immunosuppressed patients and those with preexisting lung disease. The lung epithelium is the first point of contact for inhaled fungal pathogens and is important in shaping the ensuing immune response. This application seeks to investigate how fungal invaders inhibit the immune responses generated by the lung epithelium and thus facilitate the development of a lung infection.